mRNA biological pacemaker

For those with symptomatic bradyarrhythmia, implantable pacemakers are the only treatment. While effective,
the device therapy is burdened with complications directly related to the indwelling hardware such as device
malfunction and infection. As an alternative to device pacing, biological pacemakers offer an original approach
to cardiac pacing. In this proposed project, we will test the idea that mRNA-based transgene expression suffices
to reprogram ventricular myocytes to pacemaker cells in vitro and in situ, thereby creating ventricular pacing in
vivo. The concept of this approach is novel in that an inherently short-lived gene delivery method using mRNA
can deliver therapeutic modalities that require long-term function. The scientific premise for this idea is supported
by our preliminary data that the transgene is an inherently short-lived protein, that ventricular-to-pacemaker
cellular reprogramming occurs within the time window of the transgene expression, and that mRNA-based
transgene expression creates de novo pacing in vitro and in vivo. The proposed project will translate this concept
as a preclinical study by employing complexing synthetic mRNA with lipid nanoparticle (LNP) in a formulation
that has already been approved and tested successfully in clinical trials. The objective is to evaluate clinical
feasibility and safety of this approach with a goal to identify target clinical populations toward the first-in-human
trial.

Public health relevance
Messenger RNA (mRNA)-based vaccines have invigorated gene therapy approaches that have relied on viral vectors. The brief lifetime of mRNA is fitting for therapies that require transient gene expression such as vaccines, but not adequate for therapies that require long-term transgene expression. The goal of this project is to test mRNA-based somatic cell reprogramming as a novel approach to enable lasting cardiac cell type switch and durable therapy.